Chemical Probes to Study Metal Biology

Project Summary/Abstract
Copper is an essential metal nutrient that plays important roles in human health and disease. The potent redox
activity of copper is required for a diverse array of physiological processes including respiration, antioxidant
defense, neurotransmitter synthesis, and wound healing. However, dysregulated copper homeostasis can
contribute to metabolic diseases like obesity and diabetes as well as cancer, heart disease, and
neurodegenerative disorders, often through aberrant oxidative stress and damage pathways. To help decipher
the contributions of copper to healthy and disease states, we are developing new chemical tools to enable
copper-specific imaging in living systems across a broad range of biological models, from subcellular
compartments to cells to whole animals. The scientific premise is that building a copper imaging toolkit will
provide foundational chemical reagents to further our understanding of the roles of copper in both physiological
and pathological situations. This competitive renewal application is driven by design innovations where we invent
new generalizable, activity-based sensing platforms for copper detection, as well as scientific rigor in the
synthesis and use of multiple characterization techniques to apply these tools in cell and animal models.
Specifically, we will pursue protein-labeled copper probes to study how copper is stored, trafficked, and utilized
at the subcellular level, chemiluminescent indicators to enable dynamic and longitudinal copper imaging at the
live animal level, and studies to probe how copper contributes to managing oxidative stress in neuronal cultures
and regulating neural circuitry and behavior in zebrafish models.

Public health relevance
Project Narrative (Public Health Relevance Statement) Copper is a required metal nutrient for essential physiological functions spanning energy generation, antioxidant defense, neurotransmitter synthesis, and would healing. Too little or too much copper in localized parts of the body, resulting from a combination of genetics, environment, diet, and lifestyle, is connected to metabolic diseases including obesity and diabetes as well as cancer and heart and neurodegenerative diseases. We are developing new chemical tools for imaging copper in living systems to help decipher how copper contributes to healthy and disease states, focusing on the contributions of copper in regulating neural function and managing oxidative stress in the brain.